Community Engagement Core (CEC)

Abstract
The Community Engagement Core (CEC) works to address the health impacts of environmental hazards on communities in our region. Mirroring thefocus of the Duke University Superfund Research Center (DUSRC) on neurodevelopmental health impacts of early-life co-exposures to polycyclic aromatic hydrocarbons (PAHs) and metals, the Community Engagement Core (CEC) will engage with communities in Durham and Navassa, NC, experiencing exposure due to geographic proximity to hazardous sites and exacerbated health risks from exposures due to social determinants of health1–10. The CEC’s holistic, three-tiered approach to prevention and intervention is based on the environmental health literacy framework11–14, generating awareness of, and promoting self-efficacy to reduce early life exposure to PAHs and metals by generating solutions at the individual, community, and policy levels. Co-produced in collaboration with our extensive network of our community partner organizations in the two geographic areas, and in accordance with their expressed interests and needs, the proposed CEC initiatives will facilitate bidirectional communication between affected communities and Center researchers and trainees, other SRPs and local, state and federal agencies. The first initiative will promote individual awareness and self-efficacy to reduce exposure among pregnant women and children in Durham, NC, through report-back and bidirectional communication. In collaboration with Project 1 and the Administrative and Research Translation Core (ARTC) and Data Management and Analysis Core (DMAC), the CEC will apply best practices in risk communication and employ effective report-back and bidirectional communication strategies to develop accessible, culturally appropriate communication tools that promote informed decision-making and empower individual participants to take action to reduce exposures. Secondly, the CEC will foster community level awareness of and the capacity to investigate and reduce exposures through Environmental Health Academies, co-developed and implemented with partner organizations in Durham and Navassa. The content of these Academies will be developed based on community interests and concerns and in conjunction with our community partners, DUSRC researchers and trainees from Projects 1, 4, and 5 and the Analytical Chemistry Core (ACC), DMAC, and Research Experience and Training Coordination Core (RETCC), as well as relevant local, state, and federal agency stakeholders. Lastly, we will build the capacity of affected communities to assess and utilize environmental health data to promote more effective policies aimed at reducing exposure. In conjunction with our community partner organizations in Durham and Navassa, the CEC will collaborate with the ARTC, RETCC, and DMAC to synthesize and report aggregate results of DUSRC research, summarize related policies and policy processes, and facilitate participatory planning to develop community-identified policy actions that promote exposure reduction and network with local, state, and federal policy and decision makers.

Public health relevance
Project Narrative The Community Engagement Core (CEC) will engage with communities in Durham and Navassa, North Carolina, experiencing exposure due to geographic proximity to hazardous sites and expected exacerbated health risks from exposures due to social determinants of health1–10. The CEC’s holistic, three-tiered approach to prevention and intervention is based on the environmental health literacy framework11–14, with a focus on generating awareness of, and promoting self-efficacy to reduce exposure to chemical contaminants by facilitating bidirectional communication between affected communities and Center researchers and trainees, other SRPs and local, state and federal agencies. Co-produced in collaboration with our extensive network of community-based and community-serving organizations in the two geographic areas, the CEC aims to generate solutions to reduce early life exposure to PAHs and metals at the individual, community, and policy levels through the following approaches: 1) promote individual awareness and self-efficacy to reduce exposure among pregnant women and children in Durham, NC, through report-back and bidirectional communication mechanisms; 2) foster community level awareness of and the capacity to investigate and reduce exposures through co-developed Environmental Health Academies; and 3) build the capacity of affected communities to assess and utilize environmental health data to promote more effective policies aimed at reducing exposure.